Collaborative Pediatric Critical Care Research Network - Clinical Site

PROJECT SUMMARY/ABSTRACT - Duke University
Our overarching objective in joining the newly organized and expanded Collaborative Pediatric Critical Care
Research Network (CPCCRN) as a new site is to enhance the scientific breadth and reach of the network to
maximize its public health impact and improve outcomes for critically ill children. Our site, consisting of Duke
University (primary site) in Durham, North Carolina, and the Medical University of South Carolina (MUSC;
ancillary site) in Charleston, South Carolina, provides comprehensive care to > 4000 critically ill children per
year in both states. Our sites provide access to 89 combined pediatric intensive care bed, and together, we will
ensure that all critically ill children in the Carolinas have access to cutting edge clinical trials and research
studies performed by the CPCCRN. We are committed to improving outcomes of critically ill children through
collaborative multicenter clinical research. Over the past 3 years, we have enrolled >400 critically ill children in
15 clinical studies conducted at Duke and coordinated by leading multicenter clinical research networks. Our
site based research team is supported by a comprehensive departmental and school of medicine wide clinical
research infrastructure that provides full service administrative, financial, regulatory, and scientific support. Our
proposed research coordinator, Mrs Harward, has >5 years of experience conducting multicenter clinical trials
in critically ill children. Our proposed principal investigator, Dr. Hornik, has dedicated his professional life to
improving outcomes of critically ill children through the development of safe and effective drugs and
interventions. Dr. Hornik is board certified in pediatric critical care medicine and cardiology, has advanced
training in biostatistics and pharmaceutical sciences, and a track record of enrolling critically ill children in
clinical trials and mentoring early-career investigators. As a faculty member in both the Department of
Pediatrics and the Duke Clinical Research Institute (DCRI), the world’s largest academic research
organization, Dr. Hornik built a research and leadership portfolio ideally suited to enhance the scientific breadth
of the CPCCRN. Leveraging our experience coordinating large multicenter pediatric clinical research networks,
including the NICHD funded Pediatric Trials Network, the FDA supported Global Pediatric Clinical Trials
Network, and the NCATS Trial Innovations Network, and the resources accessible through the Division of
Quantitative Sciences and the DCRI Pharmacometrics Center, we will provide deep scientific expertise and
training and mentoring opportunities for CPCCRN investigators in the areas of clinical pharmacology, real-
world evidence generation, and regulatory science. Through our clinical reach and scientific expertise, we will
contribute significantly to the success of the CPCCRN, development of talented clinician scientists, and
completion of our highly innovative clinical trial aimed at reducing the morbidity and mortality of MODS in
critically ill infants and children.

Public health relevance
PROJECT NARRATIVE - Duke University By joining the newly organized and expanded Collaborative Pediatric Critical Care Research Network, Duke Children’s and our ancillary site at the Medical University of South Carolina will enhance the scientific breadth and reach of the network. Our sites are the leading academic centers in North and South Carolina, and will ensure that critically ill children in both states have access to the cutting edge clinical trials and research studies conducted by the network. Building on our experiences and expertise, we will provide deep scientific expertise and training and mentoring opportunities to enrich the network with a focus on the areas of clinical pharmacology, real-world evidence generation, and regulatory science.